BIOMEDICAL IMAGING RESEARCH NETWORK

at the top of each printed page and each continuation page. RESEARCH GRANT TABLE OF CONTENTS Page Numbers Face Page ........................................................................................................................................... 1 Description,